Training Program in Imaging Sciences in Translational Cardiovascular Research

Advances in imaging technology lead to discoveries in science and medicine. Conversely, pressing questions in
science and medicine drive innovation in imaging technology development, underscoring the fundamental
symbiosis between imaging and biomedical research. The necessity to connect imaging and biomedical science
is particularly salient in cardiovascular research, where imaging the heart and vascular system, from whole organ
to molecular levels, figures prominently in the translation of discoveries to bedside diagnosis and treatment. As
such, imaging scientists must understand what questions are important in biomedical research, while biomedical
scientists must be fluent in the imaging technologies that can facilitate discovery. Our inaugural T32 program
(2016)– the first in Cardiology at University of Pittsburgh – was motivated by the recognition that there is a paucity
of scientists who can adeptly commute between the imaging science and biomedical research spheres,
ultimately compromising the translational relevance of research efforts, and contributing to the “Valley of Death”
separating basic discovery and clinical application. To bridge this chasm, our new T32 Program used an
innovative educational paradigm to train clinical and basic researchers in a broad spectrum of cutting-edge,
multimodality imaging platforms as they pursue hypothesis-driven research, with an emphasis on translational
cardiovascular research. While T32s at other institutions focus on traditional cardiovascular imaging tools (e.g.,
MRI, Echo), our T32 is unique in integrating biological imaging within the biological and physical sciences. Our
program was designed such that post-doctoral trainees (MD or PhD) acquire “core competencies” in imaging
methods spanning molecular to whole organism (“imaging tool kit”), and translational research methods spanning
basic to population levels (“translational tool kit’) – accomplished through a co-mentorship structure, with each
trainee having one mentor from imaging sciences and another from the biomedical science arena. Our approach
is structured around Individualized Development Plans that have quantifiable milestones, e.g., presentations,
publications, grants, didactic courses, or completion of Master’s degrees. Now 4.2 years into our first funding
cycle, we seek competitive renewal of our program based on its compelling premise and unmet training need;
its occupancy of an important niche in the NHLBI portfolio (only 2% of NHLBI T32s are imaging-focused); the 37
excellent, scientifically diverse, well-funded training faculty; and the successful outcomes of our nascent program
thus far. In our 2019 Cardiology Fellowship match for 8 positions (>700 applicants), 4 were filled by MDs
committed to our T32 program, highlighting our mandate to train future MD scientists. Dr. Villanueva, a
cardiologist, imaging specialist, and researcher with extensive mentoring experience, has ably led our young
program alongside 3 seasoned co-Directors and Advisory Boards. Our T32 is enhanced by institutional
endowments, research Cores of the Heart, Lung, Blood, and Vascular Medicine Institute, a rich infrastructure
from the Clinical Sciences Translational Institute, and interactions with other institutional translational T32s.

Public health relevance
PROJECT NARRATIVE Imaging in the biomedical sciences – from the individual molecule to the entire body – is a critical component of research which drives some of the most important discoveries of our time. The development of imaging technologies by scientists should be informed by a knowledge of the important targets around which to develop an imaging strategy and conversely, biomedical researchers should be fluent in the broad range of imaging platforms available to optimally design their studies – a reciprocal relationship that will foster the kind of scientific discovery that can be translated to the bedside. This Program aims to train post-doctoral fellows to acquire core competency in imaging technologies across a broad spectrum, to achieve fundamental proficiency in tools for translational research spanning basic to clinical investigation, and to use these tools to pursue hypothesis-driven research, with a focus on cardiovascular medicine.